Integrated Physiology Training: Molecule to Organism

Project Summary
Scientific training in the Physiological sciences in the U.S. has undergone a transformation largely toward
molecular mechanisms and away from whole animal integrative physiology, creating a shortage of scientists and
educators with mastery of integrative physiology. The Physiology training program at the Medical College of
Wisconsin (MCW) is an exception to this trend. Our training program offers multidisciplinary instruction and
cutting-edge integrative physiology research training emphasizing the integration of knowledge from the
molecule to cell to organ to organism. Trainees develop the critical thinking, integrative reasoning, and technical
skills participating in research focused on the prevention and control of HLBS diseases such as hypertension,
metabolic disease, epilepsy and chronic respiratory diseases. Our current proposal maintains a focus on critical
thinking, organ systems physiology and translational research training with enhancements in: 1) interdisciplinary
instruction, 2) self-directed learning, 3) the trainee candidate pool, 4) the acceleration of reaching training
milestones, 5) instruction in rigor and reproducibility in the scientific method, and 6) the recruitment of students
from populations underrepresented in science and medicine. Trainees are recruited nationally from
geographically diverse areas and selected on a competitive basis on undergraduate academic credentials,
previous research experience, and commitment to a career in research in the Physiological Sciences. Students
are full-time PhD candidates, and must successfully complete the course and research requirements, including
passing the Qualifying Exam before being considered for NIH training grant support. Selection of T32 trainees
will be based on several performance metrics in coursework and research productivity, in addition to the
alignment of their research focus in the Physiological sciences and the candidate’s potential for a successful
career in the biomedical sciences. An innovative feature of the training program is to meet the anticipated need
to train students in integrative physiology to meet the growing need for such expertise in the era of Team Science
and in the post-genomic era. Research training is under the direct supervision of highly skilled and experiences
faculty preceptors in the basic sciences (primarily Physiology) and enhanced by clinical faculty. Trainees will
undergo continuous evaluation of progress by Individual Development Plans that facilitate career development
and progress toward individualized trainee goals. The success of our program in training is evidenced by a high
completion rate and publication record of the twelve T32 supported graduates in the past 10 years, who had 25
first-authored and 42 co-authored publications (~5.6/trainee). The high number of co-authored publications
reflects the highly collaborative environment among our faculty and Team Science approach. Each of these
trainees has gone on to academic research, teaching or patient care positions indicative of the success of our
approach to ensuring the future of integrative physiology into the future. Based on the long-term success of our
training program, we hereby request funds to support 8 predoctoral students in each of the next 5 years.

Public health relevance
Project Narrative Since cardiovascular and respiratory diseases including heart attack, high blood pressure, obesity, metabolic disease, stroke, asthma, and emphysema are major health problems in the USA and world-wide, it is necessary to train scientists as integrative thinkers capable of pushing the frontiers of mechanistic, organismal physiology knowledge to better understand disease processes. For nearly 25 years of continuous T32 funding, we have had a strong track record of training predoctoral students in multidisciplinary didactic instruction and modern physiological research in order to prepare students to conduct physiological research using novel techniques and methods and teach future generations of physicians and scientists how the human body works in health and disease. For these and other reasons, we request funds to support eight predoctoral students each year for the next five years.